Cell cycle control of cellular metabolism through phase-specific regulation of mTOR Complex 1

Project Summary/Abstract
Cellular metabolic and biosynthetic demands change throughout the cell cycle, which critically impacts cell
growth, proliferation, and human disease. Understanding how cellular metabolism is modulated in different cell
cycle phases is fundamental to understanding the molecular mechanisms governing cell growth and
proliferation. Yet, very little is known about how metabolism changes throughout the cell cycle and how these
changes mechanistically link to the cell cycle machinery. The master metabolic regulator Mechanistic Target of
Rapamycin Complex 1 (mTORC1) is an evolutionarily conserved protein kinase complex that integrates
upstream growth factor and nutrient signals to stimulate anabolic cell growth. mTORC1 is activated in most, if
not all, proliferating eukaryotic cells, but the role of mTORC1 in controlling cellular metabolism has not been
studied in distinct cell cycle phases. Thus it is unknown whether the metabolic program induced downstream of
mTORC1 is differentially regulated throughout the cell cycle, or whether mTORC1 can play unique roles in
specific cell cycle phases. We tracked mTORC1 activity across the full cell cycle and found that mTORC1 is
acutely and differentially regulated, with its activity peaking in S/G2 and lowest in mitosis and G1. We
hypothesize that mTORC1 is a crucial effector through which the cell cycle orchestrates metabolic changes,
dynamically modulating metabolic pathways in a phase-specific manner to meet changing biosynthetic
requirements. In this planned research program, we will elucidate the cell cycle phase-specific functions of
mTORC1 by combining metabolomics and metabolic flux analysis with detailed mechanistic studies. Based on
our preliminary data, we anticipate that these studies will uncover new functions of mTORC1, along with new
regulatory mechanisms, that are not evident in studies on asynchronous cell populations, thus providing critical
new insights into the fundamental mechanisms that integrate cell cycle control with cellular metabolism.

Public health relevance
Project Narrative In proliferating cells, metabolism must be coordinated with the cell cycle to meet phase-specific biosynthetic demands, but how this coordination occurs is unknown. This project will determine the role of the master metabolic regulator mTOR Complex 1 as a crucial effector through which the cell cycle orchestrates changes in metabolism. This study will provide new understanding of the mechanisms that integrate cell cycle control with cellular metabolism, critically advancing our fundamental knowledge of how cells grow and proliferate.